Targeting epigenetic machinery to overcome myeloid cell-mediated resistance to anti-PD-1 therapy in GBM

PROJECT SUMMARY/ABSTRACT
Myeloid cell-mediated immune suppression is one of the major factors responsible for resistance to anti-
programmed cell death protein 1 (PD-1) therapy. Glioblastoma (GBM), a brain tumor with a dismal prognosis
with current standard-of-care therapy, is enriched with immune-suppressive myeloid cell subsets in its tumor
microenvironment and shows resistance to anti-PD-1 therapy. Therefore, there is an unmet need to develop
strategies to overcome myeloid-derived immune suppression in order to provide durable clinical benefits of anti-
PD-1 therapy in patients with GBM. Epigenetic machinery plays a key role in myeloid cell differentiation and
establishing specific functional profiles. However, the impact of epigenetic regulation of intra-tumoral myeloid
cells on resistance to immunotherapy has remained unexplored. The overall objective of the current proposal
is to identify key epigenetic factors regulating immune-suppressive pathways and develop a novel strategy
targeting the epigenetic regulator(s) to reverse myeloid-derived immune suppression in GBM.
In our preliminary studies, we noted that immune-suppressive myeloid cell subsets in human GBM tumors have
high expression of an epigenetic enzyme - histone 3 lysine 27 demethylase (KDM6B). GBM tumor-bearing mice
carrying myeloid-cell specific Kdm6b deletion demonstrated improved survival. Additionally, the absence of
Kdm6b increased chromatin accessibility and expression of genes associated with proinflammatory pathways
including interferon response, phagocytic ability, and antigen-presentation in intratumoral macrophages and
dendritic cells. Importantly, pharmacological inhibition of KDM6B with GSK-J4, a small molecule inhibitor,
enhanced the efficacy of anti-PD-1 therapy in GL261 tumor-bearing mice with increased infiltration of effector T
cells. Based on the preliminary findings, we hypothesize that KDM6B inhibition reprograms immune-
suppressive myeloid cells into a proinflammatory phenotype, thereby enhancing T cell-mediated anti-tumor
immunity to overcome resistance to anti-PD-1 therapy in GBM. In the current proposal, we will test our hypothesis
using three specific aims: 1) To determine the mechanism of KDM6B-mediated functional and epigenetic
regulation of phagocytosis and antigen presentation; 2) To identify the role of KDM6B in myeloid cell-mediated
regulation of T cell function and localization; and 3) To evaluate the therapeutic potential of KDM6B inhibition in
reversing the resistance to anti-PD-1 therapy. The research is innovative in the applicant’s opinion because this
proposal will be one of the first to provide systems-level understanding of the role of epigenetic regulation of
myeloid cell biology at a single-cell resolution in GBM. The proposed research is significant since it will
investigate a novel strategy of targeting the epigenetic machinery to overcome myeloid cell-derived immune
resistance to anti-PD-1 therapy in GBM. The long-term goal of this research endeavor is to develop
personalized immunotherapies with epigenetic modulators in a tumor-specific manner.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on providing mechanistic insight to develop a new and more effective treatment strategy to overcome resistance to immunotherapy in glioblastoma (GBM), a disease with dismal overall prognosis. The proposal aims to determine key epigenetic factor(s) regulating myeloid cell-mediated immune suppression and to target these epigenetic factor(s) to overcome resistance to immunotherapy in GBM. Thus, the proposed research is relevant to the part of the National Institutes of Health’s (NIH’s) mission that pertains to identification of novel strategies to overcome resistance to immunotherapy.